Structural insights into the unique activation mechanisms of receptor tyrosine kinases

Receptor tyrosine kinases (RTKs) play key roles in regulating normal cellular processes and are linked to many
human diseases. Each RTK protomer contains an extracellular region that binds activating ligands, a single
transmembrane helix, and an intracellular region that contains the kinase domain necessary for intracellular
signaling. For many RTKs, their cognate ligands form stable homodimers, and the binding of dimeric ligand to
the extracellular region of RTK drives receptor dimerization, which then brings two intracellular kinases in close
proximity, enabling their autophosphorylation. The phosphorylated kinases can further recruit effector proteins,
and thereby triggering downstream signaling cascade. This “ligand-induced-dimerization” is the long-standing
model for the activation of RTKs, and has been well characterized by extensive structural and functional
studies. Nevertheless, it has been suggested that several members in RTK family use unique activation
mechanisms. For instance, the MuSK receptor alone cannot directly bind to and be activated by its ligand
Agrin, but requiring assistance of the co-receptor Lrp4 on the muscle cell surface for activation. In addition, the
activation of TAM receptor requires not only the binding of its ligands, but also the involvement of
phosphatidylserine lipid (PtdSer) from plasma membrane. Furthermore, our preliminary structure results
showed that, different to all other RTKs, one HGF molecular can simultaneously engages two c-MET receptors
by utilizing two distinct interfaces; therefore, a single HGF is sufficient for the activation of c-MET receptor,
which represents another paradigm in activation mechanisms of RTK. The goal of this project is to study the
structures and functions of several special RTKs, including MuSK, TAM and c-MET receptors, whose
activation mechanism are still poorly understood. Solving the high-resolution structures of different unique
members of RTK family in the ligand-bound active state will explain the specific features that differentiate these
receptors from other RTKs, and reveal the common mechanism and diversification in the activation of RTK.
Aim 1 will be focused on the functional and structural analyses of MuSK receptor complex. This study will
reveal the detailed binding mode between MuSK, Lrp4 and Agrin, and explain why co-receptor Lrp4 is critical
for the activation of MuSK. Aim 2 will be focused on biochemical and structural analyses of TAM receptor in the
membrane associated functional state. The result from this study will allow us to explain the functional
importance of PtdSer in TAM activation. Aim 3 will be focused on the structural determination of c-MET
receptor in the HGF bound active state to understand why single HGF molecular is sufficient for c-MET
activation.

Public health relevance
It has been long known that different types of RTK exhibit great diversification in receptor activation and regulation. To better understand the diversification in RTK activation, we propose to determine the active structures of MuSK, TAM and c-MET receptors, three unique RTKs that are predicted to use distinct mechanisms for receptor activation. Solving the active structures of different members of RTK family will reveal similarities and differences in molecular mechanisms underlying the activation of RTK.